N-terminal acylation and sorting of Helicobacter pylori lipoproteins and their role in host response to infection

Project Summary (Abstract) Helicobacter pylori persistently colonizes the stomach in about 50% of the human
population resulting in gastric inflammation and an increased risk of developing gastric diseases including
cancer. The World Health Organization (WHO) lists gastric cancer as the third leading cause of cancer-related
death worldwide and classifies H. pylori as a type I carcinogen. Increasing incidence of clarithromycin resistance
also has led WHO to declare H. pylori a priority target for new antimicrobial development. Bacterial lipoproteins
are modified by acylation to help anchor lipoproteins to the inner or outer membrane in Gram-negative bacteria.
These proteins are an emerging target of antimicrobial development as inhibitors of bacterial lipoprotein
synthesis or localization have been identified. H. pylori lipoproteins contribute to pathogenesis in numerous ways,
including a role in delivering an oncoprotein (CagA) to mammalian cells. We hypothesize that lipoprotein sorting
and modifications are fundamentally important for H. pylori immunopathogenesis. In previous studies, we
showed that two of the three enzymes responsible for acylation of H. pylori lipoproteins and two proteins required
for localization of lipoproteins to the inner vs outer membrane are essential for growth. In the current proposal,
we will identify additional elements of the H. pylori lipoprotein localization system and determine the impact of H.
pylori lipoproteins on immunopathogenesis. In Aim 1, we will characterize lipoprotein localization in H. pylori by
identifying localization signals and previously unidentified proteins of the localization system. Further,
lipoproteins are recognized by innate receptors of the host, leading to pro- or anti-inflammatory responses
depending on the number and variety of acyl chain modifications on lipoproteins. Therefore, in Aim 2, we will
determine how H. pylori lipoproteins influence immune cell activation and inflammation by characterizing the acyl
chains present on H. pylori lipoproteins, defining how the number and variety of acyl chains affect innate
signaling, and analyzing inflammation and disease in mice infected with H. pylori strains expressing tri- vs
diacylated lipoproteins. The proposed studies will increase our understanding of lipoprotein biology and its impact
on gastric disease thereby potentiating our ability to treat H. pylori infection and gastric cancer. Results will lay
the foundation for future studies aimed at determining structure-activity relationships of novel lipoprotein
localization components, antimicrobial development, and defining the role of lipoproteins and innate signaling in
immune tolerance in H. pylori pathogenesis.

Public health relevance
Project Narrative (Relevance to Public Health) Helicobacter pylori colonizes the stomach of about half the human population, leading some to develop stomach cancer (the third leading cause of cancer death worldwide). H. pylori is the greatest risk factor for developing stomach cancer and increasing incidence of antibiotic resistance presents treatment challenges. Our long-term goals are to understand how H. pylori persists in the stomach despite an immune response to the bacteria, to characterize new targets for antimicrobial development, and to develop new therapeutic approaches.